The reach and effectiveness of technology-enhanced diabetes prevention programs

DESCRIPTION (provided by applicant): The aim of this project is to evaluate the reach, effectiveness, and costs of two patient-centered, theory-based, technology-enhanced diabetes prevention programs to initiate and sustain weight loss among pre-diabetic adults (i.e. impaired fasting glucose or impaired glucose tolerance) within a health care setting. The overall aim is consistent with the NIDDK's Behavioral/Prevention Research Program's focus on individual, family, and community-based strategies for prevention of diabetes and its complications. While evidence of lifestyle interventions that increase physical activity and improve eating habits to achieve modest weight loss in delaying and preventing the onset of type 2 diabetes continues to mount, the translation of these interventions into effective programs to health care settings with modest resources remains a challenge. The proposed research project will conduct a pragmatic clinical trial that employs a hybrid Preference/Randomized Controlled Trial (RCT) designed to compare two technology-enhanced diabetes prevention programs in achieving objectively verified weight loss relative to a standard care control at comparatively lower costs. Adult patients (18 years of age and older) at risk for developing diabetes will be randomized to either the Choice group or the Randomization group. Those patients randomized to the Choice group (n=240) will have the opportunity to choose one of two programs to participate in: 1. A 2-hour Small-Group (SG) session, with automated interactive voice response (IVR) systems targeting personal action planning to support lifestyle change and weight loss over a period of 12 months; or 2. A DVD-based intervention with the same IVR follow-up. Those patients assigned to the RCT group (n=360) will be randomized to one of three groups: 1. SG/IVR; 2. DVD/IVR; or 3. Enhanced standard-care (SC). SC includes the referral to a currently offered pre-diabetes class. Primary outcome measures include weight loss, cost, and reach of each program. Secondary outcome measures include physical activity behavior; eating behavior; and process evaluation. It is hypothesized that both the SG/IVR and the DVD/IVR interventions will produce significantly greater amounts of weight loss at 6, 12, and 18 months following program initiation than SC but will not differ from one another. We also hypothesize that the DVD/IVR will have broader reach and may be more cost-effective than SG/IVR or SC. PUBLIC HEALTH RELEVANCE: Many researchers have tried to translate intensive lifestyle interventions that can prevent diabetes into practice. Few have documented how much new programs cost or how many people they could reach. We use an innovative research design that will let us test the effectiveness, reach, and costs of different lifestyle diabetes prevention programs that use different levels of interactive technology and face-to-face support. If successful our project will result in diabetes prevention programs that are cost-effective and have broad potential health impact.

Public health relevance
Many researchers have tried to translate intensive lifestyle interventions that can prevent diabetes into practice. Few have documented how much new programs cost or how many people they could reach. We use an innovative research design that will let us test the effectiveness, reach, and costs of different lifestyle diabetes prevention programs that use different levels of interactive technology and face-to-face support. If successful our project will result in diabetes prevention programs that are cost-effective and have broad potential health impact.